Cancer Detection & Diagnosis Research-2022-Comprehensive genomic profiling of aggressive hormone sensitive prostate cancer

Despite a high rate of screening resulting in early identification of most of the 174,650 new cases of
prostate cancer in the USA, there are still about 31,620 deaths for metastatic and treatment resistant disease.
To enable gene profiling of the samples to identify prognostic and predictive biomarkers we have collected
tumor samples from 988 unique patients enrolled on two completed phase 3 trials:
 E3805 CHAARTED: ChemoHormonal Therapy versus Androgen Ablation Trial for Extensive Disease in
Prostate cancer. Sweeney et al, N Eng J Med 2015, 373(8):737-46.
 MRC PR08 STAMPEDE: Addition of docetaxel, zoledronic acid, or both to first-line long-term hormone
therapy in prostate cancer (STAMPEDE): survival results from an adaptive, multiarm, multistage, platform
randomised controlled trial, James, N. D., et al Lancet 2016, 387(10024):1163-1177.
This offers a very unique opportunity to study gene profiles and identify biomarkers associated with a good
versus poor response to hormonal therapy for metastatic hormone sensitive prostate cancer (mHSPC). This 5-
year R01 application focuses on assessing genomic profiles related to alterations of tumor suppressor genes
leading to loss of function of p53, PTEN and RB1. Preclinical and clinical data supports the hypothesis that the
presence of mutations in these tumor suppressors genes are associated with a poor response to ADT. The
samples from the two trials provide the opportunity for the first time to prospectively assess whether one or
more of these mutations can identify patients prior to starting treatment who are destined to have a poor
response to ADT. In turn, the presence of one or more of these mutations may identify patients who benefit
from adding in docetaxel early. This may allow accurate patient selection and spare patients who did not
benefit from early docetaxel the side effects of this chemotherapeutic.
We will first perform whole exome sequencing of the tumor and germline DNA and comprehensive RNA
profile using the Affymetrix platform from the CHAARTED trial to efficiently and comprehensively interrogate
the genome. We will then develop clinicogenomic models to determine whether more accurate prognostication
and prediction of benefit from early docetaxel can be achieved with a combination of variables from the exome
mutation and/or gene expression profiles (GEP) and/or clinical factors. Having locked down models, we will
then attempt to validate the prognostic and predictive models in the STAMPEDE samples.
It is also worth highlighting, this broad approach with whole exome sequencing and GEP will also allow
us to interrogate and other explore other hypotheses based on emerging preclinical and clinical data such as
those pertaining to DNA Damage Repair genes (e.g. BRCA2). This work may also lead to identification of
pathways to target to prevent emergence of resistance to ADT and improve the survival of men with mHSPC.

Public health relevance
Tumor samples collected from two phase 3 trials, E3805: Chemohormonal versus Androgen Ablation Therapy for Extensive Disease (CHAARTED) and Systemic Therapy in Advancing or Metastatic Prostate Cancer: Evaluation of Drug Efficacy (STAMPEDE) provide a unique opportunity to identify biomarkers associated with good versus poor response to androgen deprivation therapy. Moreover, it is possible biomarkers predictive of early benefit from early docetaxel, the major findings from these two trials, will be identified. In turn, the biomarkers may allow accurate patient selection for androgen deprivation therapy or androgen deprivation therapy plus docetaxel and spare patients who will not benefit from early docetaxel the side effects of this chemotherapy.